National Health and Nutrition Examination Survey 2009-2010, Kidney component

The purpose of this agreement is to provide support for all work related to evaluating kidney disease in the National Health and Nutrition Examination Survey (NHANES) data collection activities